Decoupling mitral valve-left ventricular fibrotic remodeling in degenerative mitral regurgitation via serotonin 2B receptor

PROJECT SUMMARY/ABSTRACT
Mitral regurgitation (MR) is one of the most prevalent heart valve diseases. If left untreated, patients will
experience left ventricle (LV) structural and functional alterations. These include chronic increases in wall stress
and changes in cellular and extracellular matrix response that leads to progressive LV hypertrophy and fibrosis,
leading to atrial fibrillation (AFib), heart failure, and death. The only effective, long-term treatment for MR remains
valve repair or replacement. Minimally invasive mitral valve (MV) repair and percutaneous MV replacement are
becoming stronger alternatives to open-chest, MV replacement surgery; however, they are not indicated for all
patients, may result in MR recurrence, or have limited durability. Thus, there is a pressing need to develop a
therapeutic pharmacological alternative to surgery. Furthermore, there is a need for MV-specific therapies that
also address MR-mediated LV dysfunction. Serotonin 2B receptor (5-HT2B) signaling impacts both MV and LV
remodeling; however, the interdependence between the mitral valve interstitial cell (MVIC) and cardiac fibroblast
(CF) populations remains unknown. Given our ability to selectively remove 5-HT2B from MVICs and/or CFs, we
possess the tools to decouple, for the first time, 5-HT2B-mediated MV dysfunction from LV remodeling both in
murine models, as well as in human-derived MVICs and CFs. Additionally, our recent development of novel 5-
HT2B antagonists that are unable to cross the blood-brain-barrier provides the first treatment option for targeting
this pathway for human disease. These studies will result in clarification on the causal role of 5-HT2B in MV
disease, while also examining the down-stream role of the receptor in MV-mediated LV dysfunction. We believe
that due to the dual citizenship of the 5-HT2B receptor on the MVICs and CFs, which is unique to these cell
types vs other valve and heart cells, this strategy can provide a ‘two-hit’ therapy for MV-LV disease, which
encompasses nearly all patients with MR.

Public health relevance
PROJECT NARRATIVE There is no effective medical therapy that halts the progression of mitral valve disease, which leads to left ventricle dysfunction. We have identified the serotonin 2B receptor as a mediator of both mitral valve and left ventricle disease and we have recently developed novel serotonin 2B antagonists that can be translated to humans with mitral valve and left ventricle disease. We propose to use novel animal models to decouple the role of the serotonin 2B receptor in mitral valve and left ventricle disease, and we will additionally test our new compounds to prevent disease.